Non-Invasive Seizure Forecasting System Using E-Diaries, Internal and External Factors

This career development award will provide me with an opportunity to develop the needed skills to become an
independent investigator using advanced machine learning and large-scale clinical cohorts applied to epilepsy.
The research project centers on forecasting the risk of seizures non-invasively using electronic diaries (e-diaries)
and biosensor data. It is unknown if non-invasive seizure forecasting can be sufficiently accurate to have clinical
utility. My prior retrospective work suggests that using advanced machine learning algorithms to evaluate e-diary
data (i.e., internal factors), forecasts of seizure risk are more accurate than chance forecasts. It is unknown if
enhancing these forecasts using additional data from sleep biosensors, medication adherence, stress, weather
patterns, stress, and exercise (i.e., external factors) would improve the accuracy further. Preliminary data
suggest that this additional data may be valuable. For Aim 1, this project will prospectively validate the machine
learning algorithm to forecast seizure risk in a cohort of people with epilepsy using e-diaries alone (internal
factors). The forecasts will be compared with a rate-matched random forecast as a baseline. For Aim 2, the
forecasts will be enriched using data from a wearable biosensor, automated medication adherence, as well as
information about stress, hormonal cycles and weather (external factors). The expected outcome of this study is
a validated method with higher accuracy for forecasting seizure risk using non-invasive techniques. In addition,
this project includes educational objectives through mentorship and online courses and local coursework
designed to prepare for research independence. The main educational objectives are (1) developing skills in
advanced data science techniques, (2) managing a large clinical cohort, (3) build a strong
biostatistics/informatics foundation, and (4) professional development. Dr. Brandon Westover, one of the
foremost data science experts in the field of epilepsy, will serve as the primary mentor for this project. Additional
mentorship will come from Dr. Jimeng Sun, an expert in machine learning and computer science, as well as Dr.
Thomas Travison, an expert biostatistician and clinical trialist. My goal is to establish a state-of-the-art,
independent laboratory focused on data science applied to decrease morbidity and mortality from epilepsy.

Public health relevance
The proposed research is relevant to public health because seizures affect approximately 4 million people with epilepsy in the United States. The project is relevant to the NINDS mission of reducing the burden of neurological disease. Noninvasive forecasting of seizures could profoundly improve the quality of life, decrease injuries and decrease mortality.